Human-Centered Design of a Behavioral Intervention to Reverse Small Weight Regains during Weight Loss Maintenance

PROJECT SUMMARY/ABSTRACT
Weight loss maintenance (WLM) is the most pressing issue in current obesity treatments. WLM programs
mitigate, but do not prevent, weight regain and individuals who lose weight have trouble re-instating weight
loss efforts despite having used them effectively during weight loss. Active intervention to return to weight loss
behaviors immediately following a small regain may prevent further regain and aid in long-term WLM, but has
not been systematically tested. The Maintain study examined whether a brief telephone-based coaching
intervention could help reverse small weight regains following participation in a behavioral weight loss
intervention (BWLI) compared to no intervention control. The coaching group showed statistically-significant
improvements in weight compared to the control group from pre- to post-coaching, but weights were not
significantly different at the 12-month study end point. Thus, additional research is warranted to inform
intervention modifications to maximize the long-term effectiveness of providing coaching at the point of initial
regain. This R03 small grant program for NIDDK K recipients proposal seeks to optimize and refine the
Maintain phone coaching intervention to promote recovery from small weight regain during WLM.
Specifically, the Double Diamond Model, a 4-phase human-centered design (HCD) process, will be used to
guide intervention refinement to support recovery from regains in the short and long-term. HCD focuses on
enhancing the usability of a product to improve effectiveness, efficiency, and satisfaction and can be utilized to
optimize behavioral interventions. As part of this process, for Aim 1 the research team will examine the
psychological and behavioral mechanisms of coaching and how long coaching effects persist following
intervention in the Maintain study. They will also engage in qualitative interviews with individuals with lived
experience regaining weight and recovering from weight regain. Next for Aim 2, the Maintain intervention will
be refined using data-driven design choices and HCD principles. The product of this project will be a revised
Maintain intervention protocol and materials for efficacy testing in a future fully powered randomized-controlled
trial. The research activities proposed in this R03 award will provide the opportunity to fine-tune skills Dr.
Hayes has developed through the K23, including skills related to longitudinal data analysis and intervention
development, and facilitate their application to WLM. This award will be integral to completing her transition to
independence by opening up a new, but related, program of research that will directly lead to an R01
submission and a potentially unique and promising model for the management of obesity as a chronic disease.

Public health relevance
PROJECT NARRATIVE Most individuals who lose weight will regain much of their weight back and existing weight loss maintenance treatments mitigate, but do not prevent, weight regain. This project will use human-centered design methods to refine a promising weight loss maintenance intervention targeted towards reversing small weight regains. The finalized intervention produced by this project has the potential to provide an alternative model for the long-term management of obesity as a chronic disease.